ACTG 328--RECOMBINANT HUMAN INTERLEUKIN 2 IN SUBJECTS WITH HIV

This study is comparing intermittently administered recombinant human interleukin-2 with a highly active antiretroviral regimen to highly active antiretroviral therapy alone in subjects who are HIV positive.